Linking Conformational Dynamics to Activity Impairment of Disease-associated Human Enzymes

Project Summary/Abstract
Motions through a complicated conformational landscape are almost certainly central to enzyme activity. This
project aims to test the hypothesis that residue replacements distant from the active site impair activity in human
disease-associated missense variants by altering protein dynamics. These proof-of-concept studies will use
asparagine synthetase (ASNS) and its variants linked to asparagine synthetase deficiency (ASNSD) as a model
system. Leveraging my expertise in mechanistic enzymology, protein dynamics, and the development of high-
throughput screening assays, we will combine enzyme kinetics, hydrogen-deuterium exchange mass
spectrometry (HDX-MS), and cell-based assays to correlate changes in conformational dynamics with the altered
catalytic activities seen for two representative ASNSD-associated variants (ASNSDVs). Time- and temperature-
dependent HDX-MS will be used to place the dynamic differences between the wild-type ASNS and the
ASNSDVs on a quantitative basis. A cell-based functional complementation assay will also allow us to examine
how hydrophobic residue networks permit distal residue changes to affect individual steps in complicated kinetic
mechanisms. Project outcomes will clarify how missense mutations that are distal to the enzyme active site lead
to activity impairment and will lay a strong foundation for applying this general approach to understand 1,500
human enzymes linked to 2,500 inherited diseases.

Public health relevance
Project Narrative Conformational dynamics lies at the heart of enzyme function. Linking changes in conformational dynamics to activity impairments caused by loss-of-function missense mutations in disease-associated enzymes will enhance our understanding of the molecular mechanisms of enzyme catalysis and lay the foundation for developing novel approaches to modulate the activity of disease-associated enzymes in the future.